Optimization of biofluid ex-RNA isolation and characterization.

DESCRIPTION (provided by applicant): The complications of myocardial infarction contribute to 550,000 cases of heart failure (HF) and 300,000 cases of sudden cardiac arrest (SCA) annually. HF and SCA are mechanistically linked to the closely related processes of mechanical and electrical remodeling of the heart following infarction. Markers of adverse remodeling are widely used to risk-stratify post-MI patients for medical or device therapies. However, current risk-stratification strategies lack adequate sensitivity and specificity. Thus, development of complementary biomarkers to predict adverse outcomes post-MI is needed for the appropriate and cost-effective applications of these advanced therapies. Cellular micro-RNAs (miRNAs) regulate entire gene networks in human cardiovascular diseases and circulating miRNAs can be used as integrative biomarkers. We now propose to identify novel circulating miRNA signatures that can prognosticate susceptibility to arrhythmia/SCA and HF post-MI and to integrate these biomarkers into a digital PCR-based assay readily translatable into the clinic. Our group of investigators spanning multiple discipline within cardiovascular research will test the central hypothesis that (1) unbiased profiling of circulating plasma using RNA-seq will identify novel miRNAs associated with the development of adverse mechanical and electrical remodeling in a cohort of extensively-phenotyped post-MI patients; (2) mechanistic animal and cell culture models will complement the clinical discovery efforts by helping prioritize those markers that play a functional role in disease pathobiology, and (3) the assessment of miRNA signatures of adverse remodeling will enable accurate prediction of clinical outcomes, notably SCA and HF, in a large cohort of patients with CAD and MI. We believe that our results will lay the foundation for a novel strategy of risk-stratificationfor post-MI patients that would allow for identification of patients at high risk of adverse electrical and mechanical remodeling, who may benefit from more aggressive monitoring and interventions with medications and ICDs.

Public health relevance
PUBLIC HEALTH RELEVANCE: The complications of a myocardial infarction (heart attack) such as heart failure and lethal arrhythmias lead to significant morbidity and mortality. Current tests to predict which patients are at risk of these complications are imperfect. We seek to develop novel blood tests to identify patients at risk of developing these complications so that they can be treated prophylactically. __SpecificAimsTextDelimiter__ SPECIFIC AIMS Despite dramatic improvements in the management of myocardial infarction (MI)1, its sequelae of adverse mechanical and electrical remodeling persist and contribute, respectively, to 550,000 cases of heart failure (HF) and 300,000 cases of sudden cardiac arrest (SCA) annually2, 3. Mechanical and electrical remodeling is intertwined. Impaired cardiac systolic function [left ventricular ejection fraction (LVEF) <35%], a surrogate for mechanical remodeling, is a predictor of SCA and widely used to risk-stratify post-MI patients for therapy with implantable cardioverter defibrillator (ICDs)4, 5. However, current risk stratification strategies lack adequate sensitivity and specificity2. Thus, development of complementary biomarkers to predict adverse outcomes post-MI is needed for the appropriate and cost-effective applications of these therapies. Cellular micro-RNAs (miRNAs) regulate entire gene networks in human cardiovascular diseases6, including fibrosis and arrhythmias7-9. Circulating miRNAs can be used as integrative biomarkers10, 11. Accordingly, our group has identified circulating miR-30d as a predictor of improved LVEF after cardiac resynchronization therapy in HF. In addition, we have recently developed a digital PCR-based multiplex screening assay for simultaneously assessing levels of multiple different miRNAs from plasma. We now propose to identify novel circulating miRNA signatures that can prognosticate susceptibility to arrhythmia/SCA and HF post-MI and to integrate these biomarkers into a digital PCR-based assay readily translatable into the clinic. Our group of investigators spanning multiple disciplines within cardiovascular research will test the central hypothesis that (1) unbiased profiling of circulating plasma will identify novel miRNAs associated with the development of adverse mechanical and electrical remodeling in post-MI patients; (2) mechanistic animal models will complement the clinical discovery efforts and help identify markers for further investigation and validation; and (3) the assessment of multiple miRNA biomarkers will enable accurate prediction of SCA and HF in patients with CAD and MI, and may provide future therapeutic targets. We will address this hypothesis with the following specific aims: Specific Aim 1: To discover a signature pattern of plasma miRNAs associated with electrical and mechanical remodeling in a cohort of post-MI patients. In 374 patients at 4 weeks and 6 months post-MI, we have performed cardiac MRI (for scar assessment, ventricular function) and microvolt T wave alternans (surrogate for arrhythmic risk) and collected peripheral blood (RO1-HL091157). From this effort, we have selected 9 patients with and without SCA ("arrhythmic" cohort) and 9 patients with and without adverse LV remodeling (by LVEF, "mechanical" cohort), matched for scar size, age, and gender. We will use RNA-seq on RNA isolated from plasma to identify candidate miRNAs whose levels differ between cases and controls in each cohort. Specific Aim 2:To characterize the functional significance of candidate prognostic RNA biomarkers. We will use primary cardiomyocyte (CM) cell culture models and animal models of LV remodeling after ischemia/reperfusion (I/R) to identify those miRNAs from SA1 that are mechanistically related to ischemic remodeling in the heart. Those miRNAs from SA1 that (1) are expressed by cardiac cells, (2) play a role in CM survival/apoptosis in vitro, or (3) change expression during I/R will be prioritized for investigation. Gain- and loss-of-function experiments for selected miRNAs will be tested in the I/R model to determine their role in adverse remodeling. We hypothesize that this strategy will yield the most robust biomarkers to move forward. Specific Aim 3: To clinically characterize novel plasma miRNA biomarkers of adverse post-MI remodeling. As part of the UH3 phase, we will validate our candidate biomarkers in two stages. Prioritized miRNA signatures will be characterized in the SA1 patient cohort as predictive biomarkers of adverse mechanical and electrical remodeling using the high-throughput multiplex digital-PCR based platform. These assays will next be applied to cohorts of healthy but 'at-risk' patients to assess normal circulating levels of candidate miRNAs. Specific Aim 4: To validate the prognostic utility of novel miRNA biomarkers of post-MI HR & arrhythmic risk. In this specific aim, we will test the hypothesis that our miRNA signature will improve post-MI risk stratification for arrhythmias and future development of HF. Using our digital PCR assay, we will test levels of candidate plasma miRNAs in 4000 patients from the MERLIN-TIMI 36 trial, which enrolled patients with a non-ST- elevation MI12. Patients had continuous ECG recordings for the first 7 days and were followed for a median of 1 year for SCD and HF. Use of the TIMI Study Group trial cohort offers the advantage of careful cardiac phenotyping and adjudicated clinical outcomes. We will use state of the art computational and statistical tools to determine if our candidate biomarker panel improves prediction, risk stratification and net reclassification compared to the traditional clinical risk factors. We believe that our results will lay the foundation for a novel strategy of risk-stratification for post-MI patients that would allow for identification of patients at high risk of adverse electrical and mechanical remodeling, who may benefit from more aggressive monitoring and interventions with medications and ICDs.